Adolescent Binge Ethanol Dysregulation of H3K36me3 Leads to Cryptic Transcription and Lasting Memory Deficits

PROJECT SUMMARY
The prefrontal cortex (PFC) undergoes significant changes during adolescence, and alcohol exposure during
this time is particularly damaging. Consuming alcohol, especially in binges, has been shown to negatively
impact the adolescent brain, resulting in brain structural changes and lasting deficits in attention, visuospatial
skills, and memory. The underlying mechanisms of these deficits are largely unknown; however, histone
epigenetic regulation of gene expression provides an attractive mechanism for driving long-term behavioral
and cognitive changes following binge ethanol. Through interaction with environmental stimuli, such as alcohol,
epigenetic alterations can determine downstream gene expression, which in turn affects behavioral outcomes.
The proposed study will investigate whether histone epigenetic alterations are the mechanism behind the
persistent memory deficits of adolescents exposed to binge levels of ethanol. Specifically, the study will focus
on tri-methylated histone 3, lysine 36 (H3K36me3). H3K36me3 has been shown to be affected by adolescent
binge ethanol, and also plays significant roles in transcription regulation and memory function. These functional
roles may provide a mechanism for how dysregulation of H3K36me3 by adolescent binge ethanol could
underlie long-term memory deficits. Additionally, H3K36me3 is an under-studied mark, and further investigation
of its role in memory function and cryptic transcription will provide valuable data for others involved in
behavioral epigenetic research. Through this proposal, we intend to determine how H3K36me3-regulated loci
and gene expression patterns within the PFC are altered after adolescent binge ethanol. By overlaying
chromatin immunoprecipitation (ChIP) sequencing with RNA sequencing data, we will determine how ethanol-
induced dysregulation of H3K36me3 affects gene expression, and at which loci these changes are occurring.
We also plan to manipulate H3K36me3 levels within the PFC to determine if altering this epigenetic mark can
change the behavioral outcomes of adolescent binge ethanol. These studies therefore have the potential to
expand the knowledge of how epigenetic alterations can induce lasting behavioral changes. The success of
these epigenetic and genomic studies will identify novel genes that might contribute to the persistent memory
deficits associated with adolescent binge ethanol, which could ultimately lead to pharmaceutical targets to
reverse cognitive deficits associated with adolescent binge drinking. Additionally, this study will facilitate my
training in molecular techniques, bioinformatics analyses, and animal behavior models. In addition to the
critical thinking, scientific writing, and professional development skills that I will be trained in, this research will
prepare me to become a successful independent researcher studying how environmental influences, such as
alcohol consumption, is encoded into the epigenome and how this can cause lasting impacts to behavior.

Public health relevance
PROJECT NARRATIVE Adolescent binge drinking can lead to persistent cognitive effects, such as memory deficits, due to disruption of prefrontal cortex development that occurs throughout adolescence. Adolescent binge ethanol has also been shown to be associated with decreased prefrontal cortex levels of histone 3, lysine 36 (H3K36), an epigenetic mark involved in transcriptional fidelity and memory consolidation. The proposed studies will determine which H3K36-regulated genomic regions are disrupted by adolescent binge ethanol, and whether these regions are associated with cryptic transcription at memory-related loci, resulting in persistent memory deficits.